Impact of Solute Carriers on Ruthenium Complex Sensitivity in Yeast

Project Summary/Abstract
Solute carriers, which include members of the Major Facilitator Superfamily (MFS), comprise a large and
understudied group of proteins with roles in diverse biological processes, including metal transport and stress
resistance. Using Saccharomyces cerevisiae as a model organism, our previous studies showed that the
clinically promising anticancer ruthenium complex KP1019 induces expression of the evolutionarily conserved
MFS protein Tpo1. However, the mechanisms driving this induction are unknown.
Given that Tpo1, like many other MFS proteins, effluxes a diverse range of toxins from cells, the KP1019
resistance of yeast lacking TPO1 is counterintuitive. Possible explanations for this surprising phenotype
include compensatory activation of other drug transporters or perturbation of polyamine homeostasis, which is
known to be regulated by Tpo1. To advance our long-term goal of determining how solute carriers, including
their regulation, modulate KP1019 tolerance, we will pursue three specific aims focused on identifying the
upstream regulators and downstream effectors of the relationship between KP1019 and Tpo1. Specifically, we
propose to 1) determine the mechanism(s) and physiological significance of TPO1 induction by KP1019, 2)
characterize the KP1019 resistance caused by deletion of TPO1, and 3) discover novel modulators of KP1019
resistance/sensitivity.
Deletion of transcription factor genes implicated in our previous studies will enable identification the
regulator(s) responsible for drug-dependent induction of KP1019. Transcriptomic analyses will inform
hypothesis-driven experiments aimed at determining the roles of compensatory activation of drug efflux and
polyamine homeostasis in the KP1019 resistance of yeast lacking TPO1. A quantitative phenomic screen of
the yeast deletion collection will aid in discovering new modulators of KP1019 tolerance, enabling
establishment of genetic markers that predict patient response to anticancer ruthenium complexes.
Furthermore, this project will enhance the research infrastructure at Furman University, creating new
opportunities for undergraduates to engage with high throughput techniques paired with hypothesis-driven
experiments, a combination that will increase their likelihood of pursuing careers in the biomedical sciences.

Public health relevance
PROJECT NARRATIVE Solute carriers, including members of the major facilitator superfamily (MFS), are an understudied class of proteins that play important roles in drug resistance, nutrient uptake, and cell signaling. Here we propose to use the budding yeast Saccharomyces cerevisiae as a model for cancer in a study the evolutionarily conserved transporter Tpo1. Specifically, our research will determine the mechanism(s) by which Tpo1 expression increases following exposure to the anticancer drug KP1019 and why cells lacking Tpo1 are KP1019 resistant.